Molecular Magnetic Resonance of Hepatic Fibrogenesis

A. Specific Aims
Identification of high-risk populations suitable for screening and chemoprevention of hepatocellular carcinoma (HCC) has been proposed as an effective and efficient strategy to impact HCC-related mortality. Screening and earlier detection of HCC has had some impact on HCC mortality. However, the absence of tools to accurately predict which patients will progress to HCC remains a significant barrier to development of effective chemoprevention agents. Progress in prediction of who will progress to HCC and whether chemoprevention is likely to be effective would have a major clinical impact.
Liver fibrosis is a common pathway shared by all progressive chronic liver diseases that raise risk for HCC, regardless of the underlying etiologies. Many lines of evidence suggest that increased fibrosis and fibrogenesis are independent predictors of HCC transformation, and that reducing liver fibrosis reduces HCC risk. Our lab has developed molecular probes for noninvasive, quantitative imaging of liver fibrosis and fibrogenesis throughout the entire liver. With a type I collagen targeted peptide-based MR probe we showed that we could accurately stage liver fibrosis in 6 different rodent models. We developed a second type of probe in prior work funded by this grant: molecular MR probes that target the aldehyde-containing allysine residue on oxidized collagen and showed that we could specifically quantify fibrogenesis (fibrotic disease activity). In this Renewal, we propose to expand this toolbox further and develop a third novel probe that targets inflammation associated with fibrogenesis (IAF). This probe is based on the low relaxivity Fe2+-PyC3A chelate which is activated by rapid oxidation to high relaxivity Fe3+-PyC3A in the presence of peroxidases released during inflammation and which then binds to allysine residues that are present during fibrogenesis, retaining the probe and its high relaxivity signal at the site of IAF. We will deploy these three probes (fibrosis, fibrogenesis, IAF) to characterize the combinations of these biochemical features that best predict transformation to HCC in rat and mouse models. Next, we will use molecular MR for real-time monitoring of response to chemoprevention agents that have been proven effective in preclinical models, and to guide effective dosing. The overarching goal of this project is to leverage molecular imaging of fibrosis to accurately predict risk of progression to HCC, and real-time monitoring of efficacy of interventions that reduce the risk.
Aim 1. Develop a turn-on molecular probe to detect fibrogenesis when it is associated with inflammation.
1.1. Synthesize a small focused library of allysine-targeted, Fe2+-PyC3A probes
1.2. Screen the probes for relaxivity in the presence/absence of peroxidase, target affinity, non-specific binding, and allysine binding kinetics to a model proteiny
1.3. Confirm the ability of the IAF probe to detect inflammation associated fibrogenesis in a mouse model of NASH/fibrosis/HCC (choline-deficient, l-amino acid-defined, high-fat diet and a single dose diethylnitrosamine (DEN) injection; DEN-CDAHFD)
1.4. Demonstrate the specificity of the IAF probe for inflammation with fibrogenesis compared to fibrosis with minimal inflammation in rat diethylnitrosamine (DEN) models of acute inflammation.
Aim 2. Define which combination of total liver collagen, liver fibrogenesis, and IAF assessed early in the course of disease by molecular MRI is predictive of worse disease progression
2.1. Image DEN-CDAHFD mice with moderate or severe liver fibrosis using CM-101 (collagen targeted probe), Gd-1,4 (fibrogenesis probe), and the AIF probe from Aim 1 and then follow these animals and determine which animals develop HCC. Compare the accuracy of the three molecular MR methods performed early in the course of disease to predict worse disease progression and to predict HCC transformation.
Aim 3. Demonstrate that molecular MR can provide an accurate assessment of efficacy of antifibrotic therapy and that molecular MR can predict the outcome of a chemoprevention intervention.
3.1. Image DEN rats with Gd-1,4 and the IAF probe two weeks after initiating erlotinib or vehicle treatment and compare the early molecular MR readouts with the amount of liver fibrosis at the end of treatment determined by CM-101 MR imaging, biochemical analysis, and histopathology.
3.2. Perform a dose response study with erlotinib in DEN rats and perform molecular MR two weeks after initiating treatment and then follow animals to measure HCC transformation histologically. We expect that disease activity at two weeks assessed by molecular MR will predict treatment efficacy and the minimally effective dose of erlotinib.

Public health relevance
Project Narrative Liver fibrosis is the formation of scar tissue in the liver that is caused by chronic damage to the LIVER that can arise from a virus like hepatitis C virus, metabolic disorders like diabetes, or from alcohol or drug abuse, and the presence of liver fibrosis increases the risk of primary liver cancer. In this project we are developing molecular probes for use in MRI that can detect the total amount of fibrosis, that can detect fibrosis disease activity, and can detect fibrosis associated with inflammation. We will test whether using these probes with MRI can predict who will progress to liver cancer using animal models, and whether we can use imaging to select treatments that could prevent development of liver cancer.